Neuronal circuits supporting learning-driven changes in auditory perception

NEURONAL CIRCUITS SUPPORTING LEARNING-DRIVEN CHANGES IN AUDITORY PERCEPTION.
Learning to discriminate sounds in noise is fundamental to auditory processing and is critically important for
everyday communication and navigation. Both the auditory thalamus and the auditory cortex have been shown as
involved in detection of sounds in noise, yet how the microcircuits within intra-cortical, cortico-thalamic and intra-
thalamic interactions facilitate detection of signal in noise remains unknown. Our goal is to close this gap in knowledge
and determine whether and how multiple microcircuits within the cortico-thalamic loop, including excitatory-inhibitory
circuits within the primary auditory cortex; feedback loop between the auditory cortex and the lemniscal and non-
lemniscal auditory thalamus; and the cortical feedback via the inhibitory thalamic reticular, contribute to the learning-
driven improvement in auditory perception in noise. We will train mice to detect or discriminate between auditory targets
in noise using operant conditioning. Detecting and discriminating sounds in noise activates multiple processes, including
selective adaptation to background noise and learned amplification of the target representation. We will change noise
contrast prior to target presentation to test how contrast adaptation interacts with target detection. We will record the
neuronal responses in the cortical and sub-cortical regions during behavior, and use temporally precise, cell specific
manipulations to establish the circuit that allows the mouse to learn and carry out this complex task. We will implement a
novel generalized linear-non-linear model to continuously estimate gain adaptation in neuronal responses to test whether
and how the distinct microcircuits adapt to contrast, detect the target and control neuronal gain. Combined, our results
will reveal novel circuit-level mechanisms for hearing in noise across micro-circuits within the cortico-thalamic loop.

Public health relevance
The goal of the proposed research is to identify the circuits for learning to hear in noise. This is achieved by using a combination of electrophysiological, imaging, optogenetic and behavioral approaches in the mouse system. Verbal communication and auditory navigation require rapid reorganization of the representation of the acoustic environment under varying behavioral demands. Patients with hearing deficits, age-related hearing loss and communication deficits, as well as patients with hearing aids and cochlear implants exhibit extreme difficulty hearing in complex acoustic environments, and especially transitioning between different environments with varying noise levels. Identifying which neuronal circuits underlie the ability to modify the representation of complex acoustic scenes, is a prerequisite for development of new and improvement of existing therapies for these large groups of patients. In particular, these important insights into the function of feedback circuits in auditory processing will inform future design of hearing aids and cochlear implants by configuring their outputs for optimal stimulation of these circuits.